Characterization of non-canonical regulatory pathways in the Caulobacter NtrYX signaling system

Project Summary/Abstract
All bacteria must sense and respond to metabolic and environmental changes to thrive in diverse
habitats. These adaptive responses are often achieved using two-component signaling systems. Two-
component signaling systems are composed of two core elements: a sensory histidine kinase and response
regulator. The histidine kinase detects a cue and phosphorylates the response regulator. In general,
phosphorylation of response regulators leads to changes in gene expression. Although canonical two-component
signaling systems are somewhat simple, it has become increasingly apparent that many systems are more
complex sensory networks, incorporating atypical features and additional regulatory components. NtrY-NtrX
(NtrYX) is an emerging example of a complex sensory system linked to diverse phenotypes in many ⍺-
proteobacteria. Prior studies have investigated NtrYX within the framework of canonical two-component
signaling. However, recent work reveals that, in the freshwater and soil bacterium Caulobacter crescentus, the
NtrYX system is more elaborate, incorporating an unidentified source of phosphorylation and a novel NtrY
regulator, NtrZ. In addition, genetic and transcriptional data suggest that phosphorylated and unphosphorylated
NtrX have distinct and physiologically relevant activities. The proposed work will investigate integrated regulatory
strategies in the C. crescentus NtrYX system at multiple levels. The first aim of this project will determine how
NtrX phosphorylation affects its DNA-binding and regulatory activities. To better understand how this
phosphorylation is controlled, the second aim will apply biochemical and structural approaches to probe the
interaction between NtrY and the NtrZ regulator. Finally, the third aim will explore an additional pathway
regulating phosphoryl-flow, employing candidate-driven and unbiased approaches to identify the in vivo source
of NtrX phosphorylation. Together, these approaches will establish C. crescentus NtrYX as a powerful model for
understanding how intersecting regulatory pathways can control two-component signaling. Our work will also
shed light on conserved and important NtrYX systems in diverse ⍺-proteobacteria, including pathogenic and
symbiotic organisms like Brucella abortus and Sinorhizobium meliloti. Moreover, this project will reveal novel and
generalizable strategies for tuning signal transduction pathways in bacteria.

Public health relevance
Project Narrative Two-component signaling systems allow bacteria to respond to environmental changes, such as those experienced during host infection, and maintain homeostasis. The proposed work will examine the complex regulatory pathways governing a two-component system critical for the proliferation of many bacteria, including organisms relevant to human health, agriculture, and the environment. This research will expand our understanding of how microbes adapt to diverse environments and, in the long term, may aid in the development of future antimicrobial therapies.